Using naturally evolved phenotypic variation to decipher the positional regulatory code of mammalian skin

PROJECT SUMMARY
Changes occurring during embryogenesis are typically lethal or can lead to congenital malformations. In many
cases, however, these changes can be beneficial because they can promote the origin of new traits and the
evolution of adaptations. Because of this relationship between deleterious and viable variation, studying naturally
occurring phenotypic diversity across the animal kingdom provides a powerful framework to study a fundamental
question in developmental biology and biomedical sciences: How can development change without detrimental
consequences? Our laboratory harnesses natural variation in mammalian skin to understand how changes
during development can generate phenotypic variation. Through work funded by my Early-Stage Investigator
R35, we have studied two distinct spatially patterned phenomena during skin development: (1) Stripe pattern
formation in rodents, and (2) Gliding membrane formation in marsupials. As proven by our track record, this work
has significantly advanced our understanding of the mechanisms by which skin is patterned. In the new funding
period, we will focus on studying stripe pattern formation in rodents to uncover the mechanisms by which skin
can acquire positional information and how such mechanisms have been modified across evolutionary time to
produce different phenotypic outcomes. To achieve this, we will build on our solid findings from previous studies,
on our exciting new preliminary data, and on the wide array of genomic and molecular tools that my laboratory
has already developed. First, using the African striped mouse as a model, we will investigate the mechanisms
by which pigment patterns are established and implemented. Specifically, we will uncover how a Wnt signaling
gradient in the dorsal skin is established; how spatiotemporal dynamic patterns of gene expression are achieved,
and what is the contribution of different hair follicle cell types to modulating differences in coat color. Then, using
a comparative approach, we will study how pigment patterns can diverge. In particular, we will study how
differences in placode patterning across species are established and we will uncover the regulatory mechanisms
by which spatial differences in pigmentation gene expression can be achieved. The approaches described in
this research program integrate multiple disciplines, including developmental biology, functional genomics, and
computational biology, with my lab’s expertise in skin developmental biology and demonstrated success
developing molecular tools in emerging model species.

Public health relevance
PROJECT NARRATIVE Because changes occurring during embryogenesis can have detrimental effects but can also promote the origin of new traits, studying naturally occurring phenotypic diversity across the animal kingdom provides a powerful framework to study how can development change without disrupting core developmental processes. Here, by studying the development of stripe patterns in rodents, we will uncover the mechanisms by which skin can acquire positional information and how such mechanisms can vary to produce different phenotypic outcomes. The approaches described in this research program integrate multiple disciplines, including developmental biology, functional genomics, and computational biology, with our lab’s expertise in skin developmental biology and demonstrated success developing molecular tools in emerging model species.